A humanized mouse model for vaginal HIV-1 transmission.

Abstract
Animal models such as small non-human primates and humanized immune system mice
(humanized mice) are valuable tools to study HIV prevention by antiretroviral drugs or vaccines.
The human bone marrow-liver-thymus (BLT) mouse model allows reconstitution of human
lymphoid cells in gut and female reproductive tract (FRT), which makes humanized BLT mice
suitable for the studies of HIV mucosal transmission and pre-exposure prophylaxis. To generate
humanized BLT mice, human fetal liver and thymus tissue are implanted under the kidney capsule
of aforementioned immunodeficient mice engrafted with autologous human HSPCs. The major
limitations of the BLT model are: 1) it requires fetal derived human cells and tissues; 2) it develops
graft-versus-host disease. Therefore, it is important to develop humanized mouse models that
utilize non-fetal derived human HSPCs to reconstitute mucosal human immune system and are
susceptible to mucosal HIV transmission. We have developed humanized mouse models that
reconstituted human lymphocytes and myeloid cells in the female reproductive tract (FRT), which
allowed robust HIV-1 infection through vaginal exposure. Using this mouse model, we propose to
investigate: 1) Propagation and dissemination of infection after vaginal exposure to HIV-1; 2)
mucosal viral reservoirs in mice treated with antiretroviral drugs; 3) Viral-specific CD8+ T cells in
the FRT of HIV-infected mice. Our proposed study will develop a non-fetal derived humanized
mouse model that allows robust reconstitution of mucosal human immune cells in the FRT to
support vaginal HIV-1 transmission. In addition, it will help us gain a better insight into the human
immune responses in the FRT, which will provide implications to the T-cell based vaccine
development.

Public health relevance
Project Narrative We have developed humanized mouse models that support reconstitution of human immune system in the female genital tract. We aim to use these models to study vaginal HIV transmission and mucosal immune response. Our study will pave the way for further investigations on vaccine-induced mucosal anti-HIV-1 immunity.